Predoctoral Training Grant in Pharmacology

The University of Colorado Denver | Anschutz Medical Campus (UCD|AMC) Pharmacology Graduate Training
Program, currently in its 39th year of NIGMS funding, and requests annual support for 7 predoctoral students
during the next five years. The Training Program distinguishes itself by providing a highly interactive
environment in which students obtain a broadly based integrative perspective on science, training in the
fundamental knowledge defining pharmacology. The Principle Investigator for the Training Grant is Dr. Mark
Dell’Acqua, Vice Chair of the Department of Pharmacology. The Training Program Director is Dr. David Port,
who Chairs the Graduate Training Committee (GTC), which provides the day-to-day oversight for this Training
Program. The 47 members of the Training Program faculty are drawn numerous departments within the School
of Medicine, and have been recruited to provide broad, multidisciplinary training opportunities in
neuropharmacology, cell signaling, pharmacogenetics, cancer biology, biomolecular structure, and
bioinformatics. Training Program faculty are all accomplished, committed researchers and mentors with
significant extramural funding. The sources of students entering the Training Program include direct applicants
to the Program, as well as students who transition from ‘umbrella’ programs (Biomedical Sciences and Medical
Scientist Training Programs). Hallmarks of the Program are a comprehensive didactic component, 3 laboratory
rotations, a strong emphasis on student presentations in seminar settings, and a wide choice of thesis
research options. Career development in the pharmacological sciences and student initiative are also
emphasized. During each of the past 4 years of this T32 funding cycle, 6 students have been supported by the
Training Grant. As a composite, the last 4 classes (Fall 2014-17) of “direct recruit” matriculated students
include 5 URM’s This represents a 29% URM matriculation rate (5 of 17 students). During the same time
period, an additional 5 students entered the Training Program, 3 MSTP’s, 1 BSP’s, and 1 transfer, for a total of
22 incoming students over 4 years, an average of 5.5/year. The Training Program currently has a total of 26
students, up from 16 at the last grant submission. Since 2013, 13 trainees have graduated with Ph.D. degrees
in an average of 5.3 years. An additional 3 trainees graduated with M.S. Degrees. The competitiveness of the
students for individual national fellowships, high quality publications in peer-reviewed journals and invitations to
participate in national meetings are all measures by which the successful training of the students is gauged.
Additionally, the retention of the graduates in academic, industry and government positions is another measure
of the success of the Training Program. With renewal of funding, this Training Program will continue to thrive
and meet the national demands for individuals, trained as pharmacologists, who are individually astute
researchers, can be multidisciplinary research team members, and also have the breadth of knowledge to
plan and communicate effectively across a spectrum of technologies.

Public health relevance
The primary objective of this Training Grant is to facilitate the education and training of the next generation of research scientists in the discipline of pharmacology, which seeks to understand how the use of chemical and biological can affect biological systems and mitigate disease. Students in the Pharmacology Training Program investigate basic mechanisms and therapeutic approaches associated with numerous important public health issues including: neurological and psychiatric disorders, cancer, immunology, microbiology, and cardiovascular medicine. Trainees are taught the process of scientific thought and its communication in both oral and written forms. !